The Arizona Department of Health Services Food Safety and Food Defense Project

Arizona Department of Health Services LFFM Grant Application Projects 1-7 Summary
The Arizona Department of Health Services Laboratory (ASPHL) has capacity in Chemical,
Microbiological, and Radiological testing to analyze food products for like contamination at both
preparedness and regulatory levels. ASPHL is a FERN Laboratory under ISO 17025
accreditation for the analysis of food defense analytes and seeks to maintain that capability in
both chemical and microbiological disciplines as well as expanding into radiochemical analysis
for the duration of the 5-year project timeline. (CHEM / MICRO / RAD Tract 1).
The ASPHL is the primary servicing laboratory for the testing of manufactured human food for
the State of Arizona and seeks to introduce chemical food safety testing for metals and
allergens on samples collected by state and county partners under the Manufactured Food
Regulatory Program Standards (MFRPS) guidelines. (CHEM Tract 2).
The ASPHL is partnered with Translational Genomics Research Laboratory (TGEN) for the
yearly sequencing of 400 isolates of Salmonella, E. coli, Campylobacter and Listeria
monocytogenes and will continue as a founding member of the FDA’s GenomeTrakr.
Subrecipient TGEN has identified greater than 1000 isolates of target organisms to consider for
whole genome sequencing on human food. (MICRO Tract 4).
Method development is a strength of the ASPHL and the Chemistry Laboratory proposes to
continue this activity with the development and validation of compliance level Allergen Testing
using the MagPix System with XPonent 4.2 software with the end product being a written
analytical method to submit to the FDA NPO for review. (CHEM Tract 4).
The ASPHL FERN Chemistry is strong on metals analysis using ICP-MS and LC-ICP-MS and
proposes to engage in a multi-laboratory validation of the Elemental Analysis manual method
EAM 4.12: Analysis of Bottled Water by ICP-MS. The method will be validated two different ICP-
MS platforms: an Agilent 7700 ICP-MS coupled to an Agilent 1200 uHPLC system and an
Agilent 8900 ICP-triple quadruple-MS coupled with an Agilent 1260 infinity II. (CHEM SP D3).

Public health relevance
Arizona Department of Health Services Narrative for LFFM Grant – Project Narrative The ADHS is applying for the LFFM Grant and seeks to continue in food defense chemistry and expand whole genome sequencing capabilities. The ADHS seeks to engage in microbiology food defense, radio chemistry food defense, and chemistry food safety capabilities.